Defining JNK-associated neurodevelopmental disorders

PROJECT SUMMARY
This proposal aims to investigate the role of the c-Jun N-terminal kinase (JNK) signaling pathway in
neurodevelopmental disorders (NDDs). NDDs, such as autism and intellectual disability, affect individuals
across the lifespan and present diagnostic and medical management challenges. Despite advancements in
genomic diagnostics and precision therapies, their application to NDDs remains limited. A key obstacle in
improving care is the inability to provide a molecular diagnosis for most affected individuals, hindering the
understanding of pathomechanisms and development of precision therapies. Loss-of-function variants in
several genes involved in the JNK pathway, including MAP2K4 and MAP4K4 identified by our group, were
recently shown as causative in NDDs. While the JNK pathway is known to play critical roles in
neurodevelopment, its relevance to NDDs remains underexplored. I hypothesize that disrupted JNK signaling
is a feature shared across an emerging class of NDD, and plays a role in non-syndromic neurologic disorders
across the lifespan. I will test this hypothesis through two main approaches: induced pluripotent stem cell
(iPSC)-based disease models to understand the effects of MAP4K4 and MAP2K4 deficiencies on the JNK
pathway in the neuronal context, and a biobank-scale investigation of individuals with rare variants among
JNK-associated genes to test if novel gene-disease relationships are identified.
The Aim 1 of this proposal will thoroughly examine neuronal cellular and organoid phenotypes in iPSC disease
models, and evaluate whether JNK pathway disruption underlies the observed phenotypes, as suggested by
my preliminary data. The experimental approach will include rescue experiments for each sub-Aim to further
determine this relationship. The Aim 2 of the proposal will evaluate other genes integral to the JNK pathways
as candidate disease genes, and will leverage biobank-scale data to test if novel gene-disease relationships
could be determined. Completion of this project will lead to better understanding of genetics of NDDs and
improve the diagnostic yield of genetic testing for cases of NDDs. The JNK pathway is heavily researched as a
drug target in other contexts, including cancer therapeutics, and my project could nominate a subset of genetic
NDDs as potential therapeutic targets. Lastly, the genotype-first disease discovery pipeline I am developing
can be repurposed to investigate additional gene-disease relationships that extends beyond NDDs.
Through the 5-year funding period, I plan to identify and describe 3 or more novel Mendelian NDDs, and
comprehensively describe JNK-associated NDDs as a distinct disease group. I plan to emerge from this period
as a leader in disease discovery with broad expertise from basic neuroscience to biobank-scale data
management and analysis. I will use the experience and discoveries as the foundation for the next stage in my
career as an independent R01-funded translational researcher with a focus on the genetics of NDDs, as well
as on therapeutic approaches inspired by the data that I will generate throughout the funding period.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental disorders (NDDs) are common group of diagnoses affecting both children and adults, including intellectual disability, which affects approximately 0.6% of the population, and autism spectrum disorder, affecting 1-3%. Despite high heritability, precise genetic diagnosis is achieved in the minority of these cases, which limits the understanding of NDD mechanisms and the development of targeted therapeutic approaches. Here, I propose a study to establish a group of NDD syndromes that share altered JNK activity as the potential mechanism, using a combination of a genotype-first, informatics-driven approach and neuronal stem cell-based models.